Nathan Shock Centers Coordinating Center

Project Summary/Abstract
The American Federation for Aging Research (AFAR) is proposing to manage a meeting in
September 2023, as part of the NIA-funded Small Research Grant Program for the Next
Generation of AD/ADRC Research. The NIA funds the research of early career investigators, as
well as investigators who are new to the field of Alzheimer’s disease research. All areas of
research are considered, including basic, translational and patient-oriented research in
disciplines relevant to Alzheimer’s disease and related dementias. Investigators must budget
travel to the meeting in their awards. Through the annual meetings and other activities,
investigators can better exchange information and network more effectively. The meetings
provide each investigator with access to colleagues who are working on similar scientific issues
related to Alzheimer’s disease, though often in different disciplines. This proposed meeting will
allow current and former grantees to: 1. foster collaboration with other grantees; 2. nurture and
develop a collective identity; 3. support career development and promote leadership skills that
help grantees become independent investigators and become the next generation of leaders in
AD/ADRD; 4. better exchange research information and network more effectively; 5. provide
access to colleagues from different disciplines who are working on similar scientific issues
related to AD/ADRD; 6. receive mentorship from nationally recognized academic leaders who
can guide the grantees’ research and career development; and 7. provide access to
organizations, programs, and colleagues that can foster the grantees’ growth and development.

Public health relevance
Project Narrative The Small Research Grant Program for the Next Generation of AD/ADRC Research supports the next generation of researchers and nurture a community of researchers who are the future of Alzheimer’s disease research. The goal of the proposed meeting is to cultivate their career development and leadership and provide opportunities for scientific exchange, collaboration, and networking.